Brain Microstructural MRI in a Piglet Model of Hypoxia-Ischemia

Project summary:
We propose to establish an integrated MR imaging and analysis platform to examine hypoxic-ischemic (HI)
brain injury in a neonatal piglet model, and to develop novel MRI markers that characterizes the evolving
cellular pathology during injury progression. While MRI has been used extensively in HI, image interpretation
and predictive accuracy of the conventional MRI markers, such as T1 and T2-weighted MRI or diffusion MRI
(dMRI), leave much to be desired. In this project, we will develop microstructural MRI markers using the
diffusion-time (td) dependent dMRI, which potentially improves the sensitivity and specificity of identifying
cellular injury in HI. td-dMRI will be achieved by measuring water diffusivity at varying td's, using an oscillating
gradient spin-echo (OGSE) dMRI sequence, to determine the td-dependency, which reflects the cell
morphology. In a mouse model of neonatal HI, we have demonstrated that td-dMRI is sensitive to small
microstructural changes in cells and subcellular organelles during early injury, and such microstructural details
are not accessible by conventional dMRI. Here we will use a clinically-relevant piglet model of whole-brain HI,
which exhibits well-defined phenotypes of gray and white matter injury that corresponds to human full-term
newborns with birth hypoxia. Development of MRI markers in this model and investigation of the
neuropathological substrates of the new MRI markers will have a high clinical impact. Clinical translation of td-
dMRI, however, is challenging due to the gradient system on clinical scanners that limits the attainable td and
detectable microstructural resolution. We will develop novel OGSE sequences to address the gradient
limitation and evaluate the clinical potentials of td-dMRI using the piglet model. The study will be performed on
3T human scanners, and therefore, the MRI techniques will be readily translatable to clinical realm.
We hypothesize that td-dMRI is sensitive to acute swelling of neurons and organelles after HI, and that early
dMRI measures are predictive of long-term neuropathologic and neurologic outcomes. In Aim 1, we will build a
piglet MRI platform with multi-metric MRI markers, including volumetric measures, high-order dMRI (DTI, DKI,
tractography), magnetic transfer imaging, along with td-dMRI measures. We will also establish atlases of the
developing piglet brains and atlas-based image analysis to achieve automated quantification of the multi-metric
MRI data. In Aim 2, we will investigate the utility of td-dMRI in detecting microstructural injury during acute and
subacute HI (6hrs - 7days), and explore the correlations between the early MRI markers with cellular and
subcellular organelle pathology. In Aim 3, we will perform multimetric MRI to follow the injury progression in
piglets over 30 days of recovery after HI, and evaluate the relations between early neuronal injury and white
matter injury in the connecting tracts, as well as the long-term functional outcome with neurobehavioral tests.
The MRI markers developed in this study will potentially improve the diagnosis and prognosis in clinical
neonatal HI, which may lead to accurate and noninvasive evaluations of adjuvant therapies in these neonates.

Public health relevance
Project narrative: We propose to develop brain microstructural assessments of neonatal hypoxic-ischemic (HI) injury in a piglet model, using a novel diffusion-time dependent MRI technique. This will be achieved on an integrated piglet MRI platform with multimetric MRI markers and atlas-based image analysis pipeline. We will investigate the neuropathologic identities of the new markers, establish the MRI signatures of the evolving cellular injury in neonatal HI, and evaluate the predictive values of early MRI measures with long-term neurologic outcomes.